Hypothalamic CRH Neurons in Diet-induced Obesity

Project Summary
The development of therapeutic drugs to cure obesity has not been successful due to unwanted side effects
and limited efficacy. Delineation of key brain neural pathways on body weight regulation is essential to fully
understand the pathophysiology of obesity and to design an effective strategy against obesity. Given the rapid
obesity epidemic coinciding with recent economic development and readily availability of high fat high caloric
diet (HFD), it is well accepted that the increased HFD consumption contribute significantly to human obesity
development. Compelling human studies also indicate a profound effect of stress on body weight regulation.
However, little is known about the neural basis of stress and HFD induced obesity. The major brain neurons
that respond to stressors are corticotropin releasing hormone (CRH) neurons, which are located in a few major
brain sites including the paraventricular hypothalamus (PVH). PVH CRH neurons help maintain bodily
homeostasis in response to stressors mainly through hormonal hypothalamus-pituitary axis (HPA) and direct
projections to down-stream neurons known to be involved in behavioral adaptation.
Our previous results demonstrate that clamping PVH CRH neuron activity at either high or low levels both
leads to reduced neuron responsiveness and exacerbates high fat diet-induced obesity (DIO), which is
associated with altered blood corticosteroid diurnal rhythms. Importantly, PVH CRH neuron responsiveness is
dramatically reduced by HFD feeding, which is known to blunt HPA axis rhythmicity. In addition, body weight-
reducing variable stress regimes in rodents augment PVH CRH responsiveness. Emerging studies also
suggest that PVH CRH neuron responsiveness changes in response to reward and regulates choices on HFD
intake. These observations lead to our central hypothesis that PVH CRH neuron responsiveness underlies
HFD-induced obesity. Experiments in Aim 1 will determine the mechanism underlying reduced PVH CRH
neuron responsiveness by HFD. Experiments in Aim 2 will identify the neurotransmitters that mediate the PVH
CRH neuron effect in DIO with a focus on CRH and glutamate release. Experiments in Aim 3 will test whether
PVH CRH neuron responsiveness mediates the known beneficial effects on metabolism induced by time-
restricted feeding and circadian rhythm enhancing Nobiletin treatment.
Results will fill in the knowledge gap in understanding the neural basis for integrating stress and HFD on
obesity. Given the growing evidence on the impact of chronic stress in human obesity, this proposal aiming to
identify PVH CRH neuron responsiveness as a fundamental mechanism for DIO is highly relevant to human
obesity and significant for obesity treatment.

Public health relevance
Project Narrative One major reason for the current obesity epidemic and its associated lack of effective treatment is due to incomplete understanding of neuronal control of complex feeding behavior. Using a combination of fiber photometry and mouse genetic approaches, the current proposal will determine whether paraventricular hypothalamic corticortropin-releasing hormone (CRH) neuron responsiveness functions as a neural basis underlying diet-induced obesity and time-restricted feeding or clock-enhancement inducing obesity prevention. The results will identify a previously unknown neural basis that dictates metabolic outcomes in response to diet changes and therefore form a foundation for effective treatments against obesity.